PROSTATE NEOPLASM--DEVELOPMENTAL PROJECTS

We will establish a developmental research which will include an internal funding program, an external funding program, as well as a mechanism for allocation of funding to each. The total budget for the developmental research program will be $250,000-$300,000 per year. The developmental research program is fundamental to the success of this SPORE. The internal funding program will constitute the foundation of these activities and will draw largely upon the research and clinical expertise at Baylor College of Medicine. The external funding component of this program will maintain current strategic associations and collaborations outside Baylor College of Medicine, in both the U.S. and abroad. We will provide for a review system that will ensure the quality of all constituents of this program and maintain flexibility with respect to the ongoing progress of the SPORE. We will provide funding for pilot projects selected as being of high priority.